SPF Rhesus Macaque Breeding Colony Expansion to Support HIV/AIDS-Related Research

PROJECT SUMMARY / ABSTRACT
The Tulane National Primate Research Center (TNPRC) of Tulane University is one of seven National Primate
Research Centers (NPRC) sponsored by the National Institutes of Health (NIH). The TNPRC is dedicated to
providing infrastructure and support for basic and applied research to advance scientific knowledge and improve
human and animal health and well-being. The TNPRC specific pathogen-free (SPF) rhesus macaque breeding
colony is among the largest in the NPRC program, with a census nearing 5000, and the TNPRC AIDS research
program is the largest research program at the Center. TNPRC’s SPF breeding colony serves as a national
resource for NIH-funded investigators and has supplied 2155 animals for research programs across the US in
the past five years, with the vast majority assigned to AIDS-related studies. Current NPRC breeding operations
cannot meet the continued high national demand for SPF rhesus macaques. The NIH-sponsored 2018 NHP
Evaluation and Analysis Project, designed to enhance understanding of the demand for and supply of nonhuman
primates (NHPs) within the US, noted that improving infrastructure and providing support for expansion of NHP
breeding colonies is necessary to ensure adequate supply of NHPs for biomedical research. The 2023 NIH-
commissioned independent National Academies of Sciences, Engineering, and Medicine (NASEM) Consensus
Study Report on Nonhuman Primate Models in Biomedical Research: State of the Science and Future Needs
recognized the worsening shortage of NHP resources for NIH-sponsored research and emphasized the
importance of NHP research resources in responding to US public health emergencies and advancing
biomedical research. The NASEM report concluded that the US needs to prioritize expansion of domestic NHP
breeding programs. Along with funding from the NIH, the TNPRC has committed funds and initiated projects to
1) improve the breeding colony management program and 2) expand infrastructure to meet the current and
projected national demand. A primary component of the long-term infrastructure improvement plan is to increase
the number of indoor/outdoor housing facilities that will provide additional protection from inclement weather and
complement existing outdoor NHP housing enclosures. The proposed project will construct indoor/outdoor
enclosures to house and breed SPF rhesus macaques on the TNPRC breeding colony campus and provide
infrastructure for current and future expansion. These facilities will support our commitment to expand production
of SPF rhesus macaques to be used for NIH-established priority research areas (AIDS-related research) at the
TNPRC and nationally. The facilities have been designed in alignment with our long-term infrastructure
improvement plan to enhance protection of animals, increase overall group housing flexibility and capacity, and
provide novel and proven environmental enhancement. The animals produced as a result of this infrastructure
improvement project will help address the national shortage of SPF macaques.